Drug and HIV Risk Among Latino Immigrant Day Laborers in Baltimore

DESCRIPTION (provided by applicant): Latino immigrant day laborers (LIDLs) are at heightened risk for drug abuse and dependence as a result of their unique social, situational and contextual circumstances. Low rates of access and utilization of drug treatment and health services and the high mobility of this primarily single and undocumented male population is of great

Public health relevance
The public health significance of this proposed research lies in the target population - the potential of Latino immigrant day laborers to act as a "bridge for infection" in the spread of HIV and other blood-borne pathogens within the Latino community, including non-drug using populations. Data will also contribute significantly to the development of targeted interventions and public health programming for this mobile population.